Development of Clinician/Researchers in Academic ENT

Project Summary/Abstract
Diseases of hearing, balance, and other communication disorders can be devastating, because they decrease
or prevent social interaction and well-being. Washington University School of Medicine has an established
reputation for outstanding basic biomedical, clinical, and behavioral health sciences research. Recently, the
university expanded its training and education opportunities in entrepreneurship, research innovation,
technology transfer, and dissemination and implementation science.
The rationale for the renewal of this long-standing and successful training program is to address the
enormous challenges that physician-scientists face today, including the rapid growth and pace of new
knowledge discovery, the boom-or-bust nature of grant-funding cycles, the growing chasm between practicing
clinicians and biomedical scientists, and the failure to incorporate women into research careers at a level
reflective of the number of women who complete medical school. With this competitive renewal, a greater
emphasis will be placed on translational science, which recognizes Washington University’s new and exciting
entrepreneurial culture of startup companies, its commercialization of biotechnology, and its increased focus
on dissemination and implementation research.
The overall goals of the Otolaryngology T32 Training Program are as follows:
(1) To introduce outstanding predoctoral medical students to the excitement and challenges of research in
an effort to stimulate an interest in research as part of their future career goals; and
(2) To train postdoctoral otolaryngology residents in the techniques of research so that they may compete
successfully for research awards and assume leadership roles in academic medicine.
The Specific Aims of the Otolaryngology T32 training program are as follows:
(1) To provide mentored research experience with faculty who are conducting clinically relevant basic,
clinical, translational, or behavioral research related to deafness and other disorders;
(2) To provide didactic core and elective coursework opportunities to ensure that trainees acquire in-depth
knowledge related to relevant research techniques; and
(3) To provide curricula, seminars, workshops, and tutorials that focus on topics related to professional
development skills.
The successful completion of these aims will result in increased numbers of diverse and well-trained
physician-scientists who will lead the multidisciplinary research teams of the future.
The training program will appoint two predoctoral medical students and four postdoctoral otolaryngology
resident physicians each year. All trainees will receive training in the responsible conduct of research. Formal
evaluation of trainees and mentors will be performed, and all trainees will be tracked to assess outcomes.

Public health relevance
Project Narrative Disorders of hearing, balance, taste, smell, speech, and language affect a significant number of Americans and, due to the nature of these impairments, can result in significant disabilities and reduction in quality of life. The goal of this training program is to introduce outstanding predoctoral medical students to the excitement and challenges of research in an effort to stimulate an interest in research as part of their future career goals and to train postdoctoral otolaryngology residents in the tools and techniques of research so that they may compete successfully for individual NIH - sponsored research awards and eventually assume leadership roles in academic medicine within the domains of deafness and other communication disorders. The successful completion of these aims will result in increased numbers of diverse, well- trained physician-scientists who will lead multidisciplinary research teams addressing complex health problems in many different populations and across the lifespan.